Revealing LIM-Domain Transcriptional Complexes that Establish and Maintain Alpha-Cell Mass

PROJECT SUMMARY/ABSTRACT
Pancreatic islets of Langerhans contain insulin-secreting β-cells and glucagon-producing α-cells that
function in concert to maintain glucose homeostasis. Dysfunction in islet activity, cell identity, or survival results
in diabetes mellitus, a disease affecting millions of Americans with numbers expected to greatly increase. It is
known that dysregulated α-cells are also major contributors to type 1 and type 2 diabetes, yet the research
focus for decades has largely been on the β-cell. Thus, the key regulators driving α-cell development and adult
function are much less defined than in β-cells. Increased knowledge of the effectors of embryonic α-cell
development will be instructive for generating ES cell-derived α-cells for islet replacement therapies, while a
greater understanding of adult α-cell functional identity will help us understand how the α-cell responds to
glucose dysregulation, likely providing novel therapeutic strategies.
We and others previously demonstrated that the Islet-1 transcription factor is required for mouse β-cell
development and function and has human gene variants that are strongly linked to islet function and diabetes.
In addition, transcriptional control imposed by Islet-1 in β-cells requires the interacting co-regulator, LDB1, with
strong evidence for Islet-1:LDB1 complex activity also in α-cells. However, nothing is known of the mouse or
human α-cell target genes and pathways governed by these factors. Interestingly, the complexity of LDB1-
mediated transcriptional control is also greater than simply through Islet-1, potentially involving other islet-
enriched transcription factors including GATA6 and/or NEUROD1. These observations support that LDB1 may
mediate multiple distinct α-cell complexes to elicit transcriptional and functional impacts.
Three complementary Aims will define comparative roles of Islet-1 and LDB1 during embryonic mouse
development and adult mouse and human α-cell function. Preliminary embryonic knockout model data
suggests that α-cell Islet-1 and LDB1 are each required to maintain postnatal glucose homeostasis. We will
further explore the impacts of α-cell-specific Islet-1 or LDB1 deficiency in developing and postnatal mice, and
in donor human islets. This proposal will test the hypothesis that Ldb1-mediated complexes comprise a central
node to regulate transcription in multiple phases of mammalian α-cell development and postnatal function,
through Islet-1 and potentially other islet transcription factors. Our extensive experience studying transcription
factor complexes and readily-available in vitro and in vivo reagents, make us uniquely suited for executing
these Aims. Results reported from this proposal will benefit efforts in developing new molecular targets and
cell-based therapies to combat diabetes.

Public health relevance
PROJECT NARRATIVE To combat the growing diabetes epidemic, islet biologists have been increasing focus on the contributions of the glucagon producing α-cell, in addition to efforts in understanding β-cells. To be successful, there must be increased knowledge of fundamental gene transcription mechanisms driving the development and function of mouse and human pancreatic α-cells. Completion of our studies will reveal how the Islet-1 transcription factor and LDB1 co-regulator complexes participate in gene regulatory mechanisms in this critical islet cell type.